Overcoming racial health disparities in lung cancer through innovative mechanism-based therapeutic strategies

SUMMARY
Development of novel therapeutics targeting cellular and molecular mechanisms underlying health disparities is
among the top priorities of Wake Forest Baptist Comprehensive Cancer Center (WFBCCC). Our thoracic
oncologists have been actively treating lung cancer patients with immune checkpoint blockade (ICB) drugs with
up to 30% efficacy in patients with non-small cell lung cancer (NSCLC). We found that Black lung cancer patients
showed significantly better response to ICB than White patients, suggesting that disparities experienced by Black
patients could be overcome with ICB. Given ICB-resistance over time, we posit that increased efficacy could be
achieved through novel ICB and targeted combination therapies. Our preliminary single-cell RNA sequencing
(scRNAseq) studies show more infiltrating exhausted CD8+ T cells and fewer myeloid and natural killer cells in
NSCLC biopsies from Black compared to White patients. In tumors from Black patients, exhausted CD8+ T cells
expressed high levels of CTLA-4 and CD137(4-1BB), suggesting a possible beneficial response to ICB by
reversing the pool of exhausted T cells to restore anti-tumor function. Transcriptional pathway analysis of
scRNAseq data also identified redox and lipid metabolism as top altered molecular changes. Based on these
findings and published data showing redox- and lipid-mediated regulation of immune cell reprogramming, we
propose two central hypotheses: (a) In Black NSCLC patients, unique features of redox and lipid metabolism
give rise to dysfunctional immune cell ecosystems that underlie health disparities, and (b) these can be exploited
by innovative redox and lipid metabolism-targeting therapeutics to further improve response to ICB. Lung cancer
is the most frequent cancer diagnosis at WFBCCC. Among patients seen at our Cancer Center, 14% are Black,
and epidemiologic data collected by our Office of Cancer Health Equity show that Black patients in our region
have lung cancer incidence and mortality rates 15.1% and 15.5% higher, respectively, than rates among Black
patients in the U.S. We are in a unique position to investigate the molecular events that lead to differences in
ICB responses by Black lung cancer patients and to develop effective therapeutic strategies to overcome health
disparities. We will achieve these goals through three Specific Aims: 1) To generate high-resolution spatial
single-cell expression profiles of tumors and the tumor microenvironment in Black and White patients with
NSCLC; 2) To generate supporting data linking specific genomic events in NSCLC from Black patients to
reprogramming of redox and lipid metabolism; 3) To generate pre-clinical data demonstrating that targeting
mitochondrial redox and lipid metabolism can reshape the tumor microenvironment and improve response to
ICB. We will use NSCLC patient-derived organoids and cell lines in humanized mouse models to determine
whether MCL1 inhibitors (AZD5991 or VU661013) and Devimistat (CPI-613) can reprogram the tumor
microenvironment and improve response to ICB. Results from the proposed research will inform future study
directions and guide potential clinical trials aimed at reducing cancer disparities in Black NSCLC patients.

Public health relevance
NARRATIVE We identified differences in tumor genomics and the status the tumor microenvironment in non-small cell lung cancer (NSCLC) between Black and White patients. We propose to evaluate drug combinations that reprogram tumor cell metabolism and induce change in the tumor microenvironment, which when coupled with immune checkpoint blockade will help to overcome the survival disparities for Black patients. Results from the proposed research will inform future studies and provide a potential direction for investigator-initiated clinical trials.